FULL PHASE TRAUMATIC COMA DATA BANK

The contractor is part of a five year multi-center traumatic coma bank project. The purpose of the project is to collect accurate data on large numbers of severly head injured patients according to precise definitions and a common data collection protocol.